Thiazolino-Pyridone Compounds as Novel Drugs for Tuberculosis

Project Summary/Abstract
Tuberculosis (TB), caused by infection with the bacterium Mycobacterium tuberculosis (Mtb), is a leading cause
of mortality due to infection, globally. In 2020, 10 million people were newly diagnosed with TB and 1.5 million
people died from the disease. As efforts to treat TB expand, the prevalence of infections caused by drug-resistant
Mtb
strains (DR-TB) that are resistant to one or more frontline standard of care (SoC) antibiotics is increasing,
in part due to the long duration (6 months) of combination therapy (4 antibiotics) for drug-sensitive TB (DS-TB),
which leads to poor patient adherence. Treatment for DR-TB is even longer, ranging from 6-24 months typically,
with 3, 4 or more antibiotics taken in combination. While the last decade has seen a TB drug development
“renaissance,” including the discovery of bedaquiline, newly approved regimens still suffer from serious side
effects and can be cost prohibitive. Therefore, new classes of drugs with new MoAs that can be combined with
existing or new TB drugs in the pipeline are desperately needed. The success of bedaquiline, which disrupts
energy metabolism in Mtb and has shown promise in reducing treatment times for DR-TB, has accompanied an
explosion of drug discovery targeting respiration in Mtb. In this application, Fimbrion proposes to develop a
thiazolino-pyridone (TZP) small molecule series with growth inhibitory activity against Mtb as a novel drug for
treating TB. While the target of this compound series is currently unknown, TZPs appear to act through disruption
of Mtb respiration. Interestingly, current TZPs not only have direct antimycobacterial activity, but they can also
potentiate the activity of isoniazid (INH), an important frontline TB antibiotic, even restoring INH activity against
INH-resistant Mtb in vitro. Our primary goal in this project is to develop a first-in-class, orally bioavailable,
antimycobacterial TZP compound that could become part of a new frontline TB drug regimen to help shorten the
duration of treatment. Currently, our most potent TZP compounds have sub-micromolar growth inhibition potency
in vitro, and favorable drug-like properties. Therefore, our primary Phase I goal will be to improve growth inhibition
potency while maintaining and/or improving the drug-like properties of the lead compounds to enable testing of
optimized compounds in an animal model of Mtb infection. Specifically, we will 1) use medicinal chemistry drug
design strategies to improve in vitro potency, metabolic stability, and solubility, and will establish in vivo
pharmacokinetic (PK) profiles (including oral bioavailability) for optimized TZPs in mice; and 2) investigate the in
vitro and in vivo efficacy of prioritized lead TZPs and generate spontaneous mutants resistant to these
compounds to better understand the bacterial target and MoA. As we have found that the antimycobacterial
potency of our TZPs tracks with their ability to potentiate INH, we will continue to spot-check this secondary
property throughout the optimization of our TZPs. Upon completion of this project, we expect to identify an
advanced lead TZP compound with demonstrated efficacy in a mouse model of acute TB, which could be further
developed in a future Phase II SBIR project as part of a combination therapy for treating both DS- and DR-TB.

Public health relevance
Project Narrative: Tuberculosis (TB), caused by the bacterium Mycobacterium tuberculosis (Mtb), is a leading cause of human mortality in the world for a single infectious agent and drug-resistance to standard of care frontline and even second-line antibiotics is increasing, highlighting the need for new therapies. In this application, we propose to develop a series of small molecule compounds for the treatment of TB, resulting in the selection of optimized drug candidates. The proposed studies have the potential to result in the development of a new family of anti- mycobacterials to be used to treat both drug-sensitive and drug-resistant TB.